Wearable nanocomposite sensor system for diagnosing mechanical sources of low back pain and guiding rehabilitation

PROJECT SUMMARY Back pain has gained the distinction of being the most disabling condition in the world [1-3], affecting 80-90% of the US population at some point in their lifetime, with 29% of the US population having experienced lower back pain within the last 3 months. Back and neck pain are the leading cause of missed work days and rank second only to the common cold as a reason for a visit to the doctor, accounting for approximately 30% of general practitioner visits. Of particular concern is chronic low back pain (cLBP), which is recurrent and often non-responsive to conservative treatments. It has long been recognized that spinal pathology changes the way that we move. Biomechanists, physical therapists, and surgeons each utilize a variety of tools and techniques to assess and interpret qualitative movement changes as a window to understanding potential mechanical and neurological sources of low back pain and as a critical element in their treatment paradigm. However, objectively characterizing and communicating this information is currently impossible, since clinically feasible (e.g., cost-effective, objective, and accurate) tools and quantitative benchmarks do not exist. This proposal addresses the challenge to improve cLBP outcomes through the use of unique, inexpensive, screen-printable, elastomer-based nano-composite piezoresponsive sensors which will be integrated into a SPInal Nanosensor Environment (SPINE Sense System) to measure lumbar kinematics and provide an objective, quantitative platform for diagnosis, monitoring, and follow-up assessment of cLBP.

Public health relevance
PROJECT NARRATIVE Our Technology Research Site team is dedicated to improving our ability to diagnose and treat low back pain. Our approach is to utilize a wearable nano-biosensing/biofeedback system to measure low back movements and incorporate that information into a platform for both diagnosis and treatment of chronic low back pain.